Optical dissection of human embryonic germ layer patterning mechanisms using microengineered stem cell models

Project Summary
In the first two weeks of development, the human embryo breaks symmetry twice, transforming itself from a
uniform ball of cells into a highly-patterned, spatially organized set of tissues. Although decades of elegant
genetics and biochemistry in non-human model organisms have uncovered many of the essential signaling
proteins and pathways for embryonic patterning at this early stage, a lack of tools for directly manipulating the
signaling in time and space, as well as limitations to working with human embryos, have limited our ability to
understand how these early patterning events arise in humans. Thus, my laboratory seeks to develop
engineering strategies to (1) understand what patterns of signaling activity encode extracellular information,
and (2) determine how these patterns are decoded at the tissue level to drive high fidelity collective cell fate
decisions in human embryonic stem cells.
This proposal brings together many recent advances in stem cell and molecular engineering to decode
how spatiotemporal signaling and embryo size instruct tissue fate patterning. We leverage advances in 2D
micropatterning, 3D bioprinting, cellular optogenetic control over developmental signaling pathways, and
CRISPR-based reporters of cell signaling pathways. Together, these technologies give us unprecedented
control over and visualization of microengineered models of human gastrulation, thereby enabling us to
investigate the principles of environmental information transmission and potential mechanisms of pregnancy
loss and developmental anomalies that arise with a surprisingly high frequency (10-20% by some estimates) in
the early human embryo. In addition, our platform does not face the same ethical barriers that have limited
human embryo research, allowing us to ascertain how physical and information-bearing parameters of the
embryo lead to stereotyped patterning of the germ layers during human gastrulation. In this proposal, we focus
on the role of canonical developmental signaling pathways by dissecting the effects of spatiotemporal signaling
and variance of the Wnt pathway on germ layer fate positioning in 2D (Aim 1); examining the role of Erk
signaling on positioning, dynamics, and coordination of cells during the development of the
mesoderm/trophectoderm boundary (Aim 2); and examining the effect of cell number and tissue size in 3D
gastrulating models of the human epiblast and amniotic sac (Aim 3).

Public health relevance
Project Narrative A significant number of pregnancies fail at very early stages in embryonic development for reasons that have been difficult to ascertain due to limitations in studying human development. We propose to investigate the developmental mechanisms the human embryo uses at these early stages to pattern its initial form through an innovative combination of micron-scale stem cell engineering technologies and optogenetic tools, that enable the systematic variation of the signaling patterns thought to drive human embryonic pattern formation. In addition to understanding these mechanisms, enhanced control of natural patterning mechanisms of human stem cells promises to boost the efficiency and precision of engineered tissues for regenerative medicine.